Characterization of Ionotropic Receptors in Mating and Blood Feeding in Anopheles mosquitoes

Project Summary
Mating, host-seeking and blood-meal-acquisition behaviors in disease-carrying mosquitoes are facilitated by an
array of chemosensory and feeding appendages that are critical for transmission cycles. In order to find a mating
partner or distinguish host odor cues (kairomones) from numerous other environmental stimuli, Anopheles
coluzzii mosquitoes use a keen sense of smell/taste that relies on at least three large families of chemosensory
receptors: these are the gustatory (AcGrs), odorant (AcOrs) and variant ionotropic (AcIrs) receptors that are
expressed in peripheral chemosensory tissues and convey information about the chemical environment to the
brain. In contrast to the highly divergent and relatively well-studied AcOr family, the AcIr family of chemoreceptors
is largely conserved and relatively poorly understood.
Preliminary studies from our group utilizing state-of-the-art transgenic reporters and gene-targeting approaches
have begun to explore the expression and function of AcIr76b, one of the triad of obligate IR co-receptors. These
studies confirm broad expression profiles and, more importantly, have begun to elucidate the essential role that
IR signaling plays in mediating responses to many odor cues that underlie important mosquito behaviors, such
as mating and host seeking/blood feeding. This has led us to hypothesize that AcIrs play a critical role in neuronal
sensitivity to as-yet undefined mating and blood-feeding cues as well as several well-established human skin
odorants in sensilla that reside on the adult antennae, maxillary palps, labella, and tarsi. For example, grooved-
peg sensilla are responsive to important human-derived kairomones—such as ammonia, lactic acid and
butylamine—yet the neurons housed within them express AcIr76b and other AcIrs but not AcOrs. In this
proposal, we seek to comprehensively elucidate the molecular functionality of AcIrs and their potential roles as
host kairomone, mating and blood-feeding receptors and thus clarify key components of the chemosensory
processes in the malaria vector mosquito An. coluzzii. Broadening our understanding of the host-seeking, blood-
feeding, and mating biology of An. coluzzii and indeed other disease-transmitting mosquitoes in which Irs are
extremely well conserved may have important future implications for human health by providing new ways to
interfere with disease transmission.

Public health relevance
NARRATIVE Female mosquitoes find their blood-meal hosts using highly specialized chemosensory appendages that are responsive to host-specific chemical cues, and mosquito behavior directly impacts disease transmission worldwide. The current proposal is designed to discover the function of an uncharacterized family of olfactory receptor genes that are likely to account for a critical portion of host odor recognition in Anopheline mosquitoes and are responsible for transmission of malaria and other diseases. Improving our understanding of mosquito chemosensory biology could ultimately provide novel ways to interfere with blood feeding and other mosquito- host interactions, potentially disrupting disease-transmission cycles.